Examining subtypes of suicidal youth in the Adolescent Brain Cognitive Development Study

PROJECT SUMMARY/ABSTRACT
The prevalence of suicidal thoughts and behaviors (STBs) in late childhood and adolescence is alarmingly high,
yet scientific understanding of STBs in youth is surprisingly limited. The NIMH has recently highlighted an urgent
need for research examining mechanisms of complex health risk behaviors, including suicide, and a prioritization
of child health research using existing datasets. The proposed study addresses these and additional scientific
priorities by capitalizing on the unprecedented methodological advantages of the Adolescent Brain Cognitive
Development (ABCD) Study to examine patterns of neurobiological, behavioral, and psychological processes,
measured across multiple units of analysis, that define distinct subtypes of youth experiencing STBs in late
childhood, as well as longitudinal associations between subtypes and STBs over adolescent development.
This proposal addresses several critical limitations of prior research on suicide. First, despite epidemiological
data that STBs frequently onset and escalate in late childhood and adolescence, suicide research has focused
primarily on adults. Second, studies of suicide are largely cross-sectional and consider a narrow set of self-report
variables. Third, most research takes a variable-centered approach and assumes a single set of risk-relevant
processes apply similarly to all individuals, despite theoretical and emerging empirical evidence supporting the
existence of multiple ‘subtypes’ of suicidal individuals defined by distinct profiles of risk-relevant vulnerabilities.
The current study addresses these limitations in multiple ways. First, the proposed work adopts a primarily
person-centered approach to examine patterns across neurobiological, behavioral, and psychological domains
that distinguish distinct subtypes of youth who experience STBs by late childhood (ages 9-10)—the age at which
suicide becomes a leading cause of death. Second, this work will test prospective associations of suicide
subtypes with trajectories of STBs into adolescence, including potentially differential risk for persistence of
suicidal ideation and/or onset of suicidal behavior. The proposal also offers opportunity to examine similar
questions in a Supplemental Aim among initially nonsuicidal children, to examine risk for new onset of STBs in
the adolescent transition. Finally, the proposal is not reliant solely on self-report and uses multimodal measures
across units of analysis, including some that are relatively novel for suicide research (e.g., neuroimaging).
In line with NIMH strategic objectives, the study will pursue these aims in the ABCD Study dataset. This dataset
offers novel opportunity to address the aforementioned limitations of suicide research with longitudinal data on
a large, heterogeneous, national representative youth sample from late childhood into adolescence. The
research has potential to reduce heterogeneity of suicide by revealing distinct suicide subtypes earlier in
development than has previously been examined. Findings can inform developmentally-salient risk models of
youth suicide, and facilitate more precise interventions and treatments based on unique subtype profiles.

Public health relevance
PROJECT NARRATIVE Suicide is the second leading cause of death for youth ages 10-14, and rates of suicidal thoughts and behaviors escalate dramatically across late childhood and into adolescence. Developmental risk for suicide, particularly in late childhood and pre-adolescence, remains very poorly understood, and research has yet to rigorously examine subtypes of youth who experience suicidal thoughts and behaviors during this developmental period using variables across multiple domains of functioning and units of analysis. The proposed research will leverage neurobiological, behavioral, and psychological data from the Adolescent Brain Cognitive Development (ABCD) Study to provide one of the first multimodal investigations of suicide subtypes among youth and associations between subtypes and STBs longitudinally, with potential to reveal a more nuanced, person-centered understanding of suicide and implications for youth suicide risk prediction and intervention.